The impact of vitamin A on the gut-mammary gland-secretory IgA axis during enteric viral infections

Project Summary. Enteric viruses are a major cause of neonatal morbidity/mortality in humans and animals. The
severe gastroenteritis and deaths in neonatal piglets caused by porcine epidemic diarrhea virus (PEDV) have resulted
in multimillion-dollar losses to the swine industry. Similar to the devastating effects of PEDV in swine, rotavirus (RV) is
a leading cause of diarrhea and mortality in children worldwide, as well as in nursing and weaned piglets. Current live
attenuated oral RV vaccines that are efficacious in developed countries, lack efficacy in impoverished countries where
micronutrient deficiencies [vitamin A deficiency (VAD)] are common. Thus, enhancing both maternal immunity and
passive lactogenic immunity via colostrum/milk, are ideal and effective strategies to reduce the impacts of viral
diarrheas in nursing neonates. An understanding of the induction of intestinal immunity during pregnancy and its role
in trafficking of virus specific plasmablasts from the gut to the mammary gland (MG) and secretion of IgA into milk [via
the gut-MG-secretory IgA (sIgA) axis] is lacking. Vitamin A (VA) has pleiotropic effects on the immune system
including induction of mucosal immunity (IgA) and trafficking of B and T cells among mucosal compartments.
However, the role of VA in induction and maintenance of lactogenic immunity against enteric viral infections is largely
undefined. Specifically, pregnant sows and women experience a decline in VA levels during the third trimester. Also
many pregnant women, particularly in developing countries, are affected by VAD, but its impact on maternal and
lactogenic immunity against enteric viruses is unknown. Recently, we observed that oral VA supplementation of
PEDV-infected pregnant swine enhances passive protection of their neonatal suckling piglets. We also showed that
prenatal VAD impairs anamnestic RV-specific IgA antibody secreting cell (ASC) responses in piglets. To expand
knowledge of lactogenic immunity, we will evaluate the impact of VA on: i) induction of virus-specific primary and
secondary (memory) immune responses in pregnant sows; ii) trafficking of virus-specific IgA ASC from intestine to
MG; and iii) lactogenic immunity-induced neonatal protection against PEDV and RV. Our Specific Aims will focus on
elucidating the effect of VA supplementation in VAD pregnant sows, compared with vitamin A sufficient sows on the
following: Aim 1) upregulation of homing molecules and trafficking of immune cells via the gut-MG-sIgA axis and
modulation of gut/MG immune responses in uninfected pregnant sows; Aim 2) enhancing lactogenic immunity after
primary PEDV infection of pregnant sows and piglet passive protection to PEDV challenge (model epidemic virus
infection); and Aim 3) maintenance and reactivation of anamnestic RV-specific IgA memory B cell responses in RV re-
exposed pregnant sows and piglet passive protection to RV challenge (model zoonotic/endemic virus infection).
Our dual purpose/dual benefit studies will enhance fundamental understanding of the gut-MG-sIgA axis,
lactogenic immunity and neonatal passive protection, applicable to swine and humans. Additionally, we will
validate use of vitamin A as an innovative, practical and cost-effective strategy to prime and boost lactogenic
immunity during pregnancy and control enteric viral infections in nursing neonates.

Public health relevance
Project Narrative. Porcine epidemic diarrhea virus (PEDV) and rotavirus (RV) are important enteric viruses that cause major neonatal morbidity/mortality in swine and/or humans. PEDV has killed over 8.5 million piglets since 2013 and RV is a leading global cause of mortality associated with childhood diarrhea; current attenuated RV oral vaccines perform poorly in impoverished countries where micronutrient deficiencies (i.e. vitamin A) are prevalent. Development of innovative and low cost strategies (such as supplemental vitamin A) to enhance maternal and lactogenic immunity is critical to reduce mortality and illness caused by these enteric viruses in nursing neonates.